Molecular imaging technologies for mechanobiology

Project Summary

Cells are highly dynamic, squeezing, pulling, and tugging on their surroundings and on each other. Each
individual interaction involves forces. These forces are felt by specific receptors and molecules. Although small
in magnitude (pN), these molecular forces can have profound biological impacts in many aspects of cellular life
including the fate of differentiating stem cells, cell division, cancer metastasis, and blood clotting. Therefore, the
ability to characterize the interplay between physical forces and biochemical signals is a critical component of
understanding signaling pathways in living systems. There are two main techniques used to study molecular
mechanobiology: single molecule force spectroscopy (SMFS) and traction force microscopy (TFM) based
methods. While powerful, these approaches suffer from several drawbacks. SMFS measures individual receptor
forces (pN), but it does so only one molecule at a time. Conversely TFM provides spatial maps of cellular forces,
but on the nN scale, orders of magnitude larger than the forces applied by individual cell receptors. To bridge
these approaches, we invented molecular tension fluorescence microscopy (MTFM) which uses conventional
fluorescence microscopy to map cellular forces with pN resolution by using a calibrated molecular force probe.
The goal of this proposal is to transform the capabilities of MTFM allowing orders of magnitude improvement in
spatial and temporal resolution as well as the mapping of force orientation. Molecular mechanobiology remains
at the fringes of biomedical sciences because of the lack of tools to precisely quantify and link mechanics to
cellular biochemistry. Our goal is to transform the field of molecular mechanobiology by developing new imaging
technologies to enable the study cellular forces at unprecedented resolution. These technologies, centered
around the DNA-­based MTFM probes, will provide a broadly applicable platform of technology to investigate
molecular mechanics, and the functional outcomes of molecular forces, in diverse biological systems. In Aim 1
we will address the spatial resolution gap, and leverage the DNA-­based force probes to develop super-­resolution
force-­PAINT with the goal of dynamic force imaging with 20 nm spatial resolution. In Aim 2 we will probe the
dynamics of forces and force fluctuations by harnessing the power of two approaches, FRAP and FCS, to study
molecular force dynamics with nsec to msec time resolution. Finally, in Aim 3 we will leverage fluorescence
polarization microscopy to measure the 3D orientations of molecular forces. We will use fibroblast focal
adhesions, platelet activation and coagulation, and T cell antigen recognition to test and verify our approach.
Accomplishment of these goals will provide a new toolkit for understanding molecular forces and generating a
framework of how force organization and dynamics influence cellular function in healthy and disease states.

Public health relevance
Public Health Relevance The proposal aims to develop new methods to visualize mechanical forces in living cells. If successful, we will be able to reveal the forces that guide cellular processes such as embryonic development, hemostasis, and tumor growth. This will improve our ability to diagnose and treat diseases ranging from cancer metastasis to stroke.